Improving the VAlidity of LInked real-world DAta sTudiEs for Diabetes Mellitus research (VALIDATE-DM)

PROJECT SUMMARY/ABSTRACT
Individuals with diabetes and their prescribers often choose among various glucose-lowering treatments
(GLTs), but information on the comparative effectiveness and safety of GLTs is limited. Most randomized
controlled trials (RCTs) only compare one GLT with placebo or another GLT in highly selective populations.
Real-world data (RWD), such as healthcare claims and electronic health records (EHRs), have been used to fill
this knowledge gap. The value of RWD is further highlighted in the 21st Century Cures Act, which emphasizes
the use of RWD and real-world evidence (RWE) to accelerate medical product innovation. RWD will likely
continue to be used, if not increasingly so, in comparative effectiveness and safety research of GLTs as a
complement to RCTs. However, individual RWD sources have well-known limitations. For example, claims
data lack certain variables (e.g., HbA1c) critical for diabetes research, while EHRs do not fully capture out-of-
system care. Linking complementary RWD sources helps overcome some of these limitations, but linked data
are susceptible to numerous biases if not analyzed properly. Given the ubiquity of and ease of access to RWD
for diabetes research, it is imperative to ensure valid findings from RWD studies. The proposed study will focus
on linked RWD for comparative effectiveness and safety research of GLTs, which is expected to be
increasingly common but with under-appreciated design and analytic challenges. Using a large claims-EHR
linked database and realistic examples, the study will address the following aims: (1) Develop a systematic
approach to investigate potential biases when using linked RWD for comparative effectiveness and safety
research of GLTs, (2) Develop and evaluate a comprehensive design and analytic approach that maximizes
internal validity in comparative effectiveness and safety research of GLTs that uses linked RWD, and (3) Apply
novel generalizability and transportability methods to improve external validity and extend findings from linked
RWD studies to target population(s) of interest. RWD studies complement and do not replace RCTs.
Sometimes they are the only way to fill our knowledge gap. The path forward is to not discredit RWD studies
but to keep improving their validity and generalizability. The proposed study is timely and critically needed. It
addresses a key topic in the 2021 NIDDK 5-Year Strategic Plan for Research – leveraging existing data for
clinical research and minimizing biases associated with RWD. The study will help the diabetes researchers
maximize the potential of linked RWD, avoid or minimize pitfalls associated with linked RWD studies and
generate robust RWE in diabetes research. The developed framework can be generalized and applied to other
linked data, such as linked claims-registries and linked EHR-registries.

Public health relevance
PROJECT NARRATIVE Information about the benefits and risks of diabetes medications can be obtained from careful analysis of data collected from clinical care. We will develop and test methods that allow us to better analyze complex data combined from different sources to help improve diabetes care.